Vanderbilt Genomic Learning Health System Clinical Site

PROJECT SUMMARY
Advances in population-scale genetic data linked to the electronic health record (EHR), along with the rise of
learning health systems (LHS) to enable the rapid translation of new knowledge to clinical care, have brought
us to the threshold of revolutionizing healthcare by using genomic medicine to predict and prevent diseases. To
cross this threshold, there is a need for a robust infrastructure to support the integration of existing genome
science advances into clinical care, and to evaluate outcomes of that integration. We propose here the
Vanderbilt Genomic Learning Health System as a Clinical Site in the genomic LHS (gLHS) Network. Work in
our clinical site will be implemented in diverse settings and in underserved populations with stakeholder
partners at Vanderbilt and the University of Miami Hospital and Clinics. Our team brings expertise in delivery of
care, basic and clinical genome science, and implementation science, and is part of an institutional
environment with recognized capabilities in integrating genomic data into the EHR, in genomic medicine, and
in clinical informatics, and includes a robust and productive LHS. The Network’s initial activity will be to select
specific projects and implementation strategies for the group. We outline three potential high-value projects
each of which builds on our team and institutional accomplishment: (1) using advanced EHR-based
phenotyping to increase identification of monogenic disorders, (2) using family health history to identify patients
at high disease risk due to actionable hereditary disease-causing mutations, and (3) personalizing genomic-
based laboratory reference ranges to avoid needless testing and increase equity in clinical medicine. We are
well-positioned to contribute to other Network-chosen projects, given our comprehensive clinical environment
and expertise in multiple domains of genomic medicine that are in advanced stages of institutional
implementation; these include pharmacogenomics, cancer genomics, and sequencing in the setting of critical
illness and in disease-specific genetics clinics. In our Aim 1, we will share our resources and expertise with the
Network to develop a data-driven framework for selecting proposed gLHS interventions and strategies. Aim 2
will incorporate the selected interventions into clinical practice, using a multi-component implementation
strategy with stakeholder engagement. Aim 3 will evaluate the effectiveness and implementation of each gLHS
intervention within our health system and across the Network, followed by refinement and re-implementation.
By identifying, implementing, and critically evaluating high value interventions across multiple and diverse
practice settings, the gLHS network represents a crucial next step in the maturation of the discipline of
Genomic Medicine.

Public health relevance
PROJECT NARRATIVE Although genetic information provides an opportunity to personalize clinical care, it is not widely used in practice. We will build a system to make genetic information a routine part of clinical medicine, working in partnership with doctors and patients to learn and share strategies that work best.